Point of use detection of low-quality pharmaceutical asparaginase

Project Summary/Abstract:
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-
CA-24-039. Lieberman is the PI of NIH 1U01CA269195, titled “Adapting a point of use test card, the
chemoPAD, for protecting chemotherapy drug quality in sub-Saharan Africa,” which is an Affordable
Cancer Technologies (ACTs) project. Champion is an investigator not named as personnel on the parent
award who brings unique expertise in LCMS of proteins required for the proposed project. We are
requesting an administrative supplement to develop tandem MS and colorimetric screening methods for
L-asparaginase, a biological chemotherapy product that has been the subject of numerous quality
concerns in the past 5 years.

Public health relevance
Project Narrative: Asparaginase is used to treat common types of blood cancer in children. We will develop a test that doctors in low- and middle-income countries can use to find bad quality asparaginase before it is given to patients.